Distinct NMDA receptor signaling domains regulate hippocampal network dynamics

PROJECT SUMMARY/ABSTRACT
Schizophrenia is characterized by discordant thought processes, perceptions, emotional responsiveness, and
social interactions impacting up to 0.7 % of the US population (National Institute of Mental Health, Health
Statistics). While rates of occurrence are low, schizophrenia ranks in the top fifteen leading causes of work
disability worldwide due to the severity of the symptoms. First episodes of schizophrenia typically occur in the
late adolescence to early adulthood. It is believed that interactions between genetic factors and aversive early
life experiences lead to abnormal brain development which produces the schizophrenia symptoms. While
widespread changes in the brains of schizophrenic patients have been documented, it is thought that the
cognitive disorganization relies on pathological processes within the hippocampus. As evidence, aberrant
network oscillations in the hippocampus in association with a selective spatial memory deficit are prominent in
schizophrenic patients. Within the N-methyl-D-aspartate receptor (NMDAR) hypofunction model of
schizophrenia, GluN2B subnits have been implicated in changes in theta and slow gamma oscillations, cross
frequency couping, and impaired spatial memory. However, this situation is made more complex by the fact
that GluN2 subunits regulate ionotropic and direct intracellular signaling and these factors have not been
addressed fully with respect to the regulation of network oscillations and memory retrieval. We created
transgenic mice expressing chimeric GluN2 subunits in the forebrain to separate the ionotropic and direct
intracellular signaling processes downstream from NMDAR activation and discovered that heightened GluN2B-
type intracellular signaling enhances long-term spatial, but not non-spatial memory performance. Since slow
gamma oscillations in the hippocampus provide the functional network organization for spatial memory
retrieval, it is possible that GluN2B-type intracellular signaling regulates slow gamma oscillations to mediate its
effects on long-term spatial memory. We propose that inappropriate GluN2B-type CTD signaling is a critical
factor in the alterations in slow gamma oscillations and spatial memory in schizophrenia. We will test this idea
and extend the question to specific synapses by analyzing theta and slow gamma oscillations, cross frequency
coupling, and spatial memory performance in transgenic mice expressing chimeric GluN2 subunits in the
forebrain or limited to hippocampal principal cells or parvalbumin-positive interneurons. We predict that
heightened GluN2B-type CTD signaling at excitatory synapses onto principal cells or interneurons will
accentuate slow gamma function during planning of paths to know goal locations and improve spatial memory.
These findings would support GluN2B-type CTD signaling as a powerful factor in the regulation of hippocampal
network dynamics and spatial memory. Outcomes from this study will transform our understanding of the
neurobiological bases of schizophrenia and provide a novel framework for future research.

Public health relevance
NARRATIVE Human and animal studies of schizophrenia implicate aberrant hippocampal network oscillations as a result of alterations to N-methyl-D-aspartate receptor (NMDAR) GluN2B subunits at excitatory synapses, however, GluN2 subunits regulate NMDAR ionotropic and direct intracellular signaling at excitatory synapses and the independent roles of these different signaling mechanisms have not been investigated with respect to schizophrenia. This pioneering proposal will extend investigation into the neural underpinnings of schizophrenia to the neurotransmitter receptor subunit domain level by exploring of the contributions of distinct GluN2B signaling domains to hippocampal network dynamics and spatial memory. Outcomes will fill important knowledge gaps in what is known of the molecular and physiological bases of schizophrenia, which will revise our understanding of this devastaing disease and enable the creation of novel treatments and potential cures.